A novel sulforaphane cancer preventionmechanism

Epidermal squamous cell carcinoma (SCC) is among the most frequent of cancers. It is treated by surgical
excision, but the recurrence and metastatic rates approach 10%. Our scientific premise is that human
epidermal cancer stem (ECS) cells are formed early in skin cancer and these cells are important cancer
prevention targets. An important goal in this context is identifying and inhibiting activity of key proteins that are
elevated and essential for ECS cell survival. Of particular interest, we show that tissue transglutaminase
(TG2), an emerging cancer stem cell survival regulator, is highly elevated in ECS cells as compared to non-
stem cancer cells. Of further importance, TG2 knockdown or treatment with sulforaphane (SFN), a promising
diet-derived cancer prevention agent, reduces TG2 activity which is associated with reduced ECS cell survival
and additional new studies indicate that TG2-knockout markedly reduces ECS cell tumor formation. We also
provide new data suggesting that SFN covalently modifies TG2 to shifts its structure to an open inactivate
conformation. These novel findings suggest that SFN treatment converts TG2 from a closed (GTP binding,
signaling) pro-ECS cell survival form to an open inactive conformation. Our goal is to characterize this unique
regulation to provide new understanding of how SFN influences this important target. We will test the idea that
SFN treatment may regulate TG2 structure via mechanisms that involve direct covalent modification, and study
the role of TG2 as a mediator of SFN action and a SFN treatment target in cultured ECS cells and tumors.

Public health relevance
Epidermal squamous cell carcinoma (SCC) is among the most frequent of cancers but is also a progressive disease that is preventable. Our preliminary studies show that transglutaminase 2 (TG2) is a key protein required for epidermal cancer stem cell survival and tumor formation. We propose that sulforaphane, a promising diet-derived cancer prevention agent, interacts with TG2 to inactivate TG2-dependent signaling to reduce ECS cell survival and prevent/reduce skin cancer tumor development.